Juvenile microRNAs promoting healthier adult aging

Summary: This proposal is responsive to RFA: Juvenile Protective Factors and Their Effects on Aging (R01)
Given their broad regulatory roles, knowledge of microRNA (miRNA) biology is essential to a
comprehensive understanding of aging. The mode of miRNA-mediated regulation is special in that
hundreds of genes can be targeted by a single miRNA while multiple miRNAs can target the same gene.
This framework commends miRNAs as key modulators of complex phenotypes by integrating multiple
biological inputs and outputs. The multiplicity of pathways and processes that are united by miRNAs leads
to highly complex network diagrams to better understand the biology of aging and for applications such as
therapeutics development. Since miRNAs have therapeutic uses, e.g. application of exogenous miRNAs to
alleviate over-expression of detrimental aging-associated genes, our hope is manipulation of miRNA levels
would be a potential therapeutic tool in diseases of aging.
My work in developmental biology inspired my move towards understanding the role of microRNAs
(miRNAs) in stem cells and cancer in more complex organisms, and towards understanding roles for
miRNAs in aging. We identified the first miRNA (gerontomiR) to be implicated in the aging process, lin-4.
Knockdown of lin-4 in Caenorhabditis elegans decreased longevity of the worms, whereas over-expression
of lin-4 increased longevity. Additionally, overexpression of miR-71 and miR-246 in C. elegans increased
longevity.
Interestingly, most of these gerontomiRs show peak expression during juvenile/larval and early adult
phases of the lifecycle, and yet are important for normal aging in adults. For example, lin-4 and let-7 play
key roles in stem cell developmental timing in larvae while miR-71 and miR-246 are required for stress
response in larvae, yet all are down-regulated in the adult and are required to promote healthy aging.
Additionally, increased expression levels of mir-71 and miR-246 in early adulthood of individual animals is
associated with longer individual lifespan. In this new work will identify additional gerontomiRs and test the
hypothesis that heterochronic expression of these gerontomiRs in the adult is capable of extending
lifespan in C. elegans.
Recently, we and other have identified various miRNAs that are up- or down-regulated during mammalian
aging, by comparing their liver or brain-specific expression in younger and older mice. We have also begun to
identify miRNAs that could be useful biomarkers of aging in humans. Given the possibility that miRNAs may
regulate processes involved in human aging, here we will also examine the aging pathways that human
homologues of the gerontomiRs identified in Aim 1 may function in and test if miRNAs regulate cell
senescence of human cells and potentially, mouse models.

Public health relevance
Narrative: We showed first that microRNAs control aging and that they act upstream of insulin and insulin-like receptor (IIS) and other known longevity pathways. In this proposal, we propose to use discovery-based and hypothesis-based methods that we previously developed to identify juvenile microRNAs with roles in aging and to test whether their heterochronic expression in older animals will affect lifespan. Since microRNAs are emerging as therapeutics, this brings up the possibility of using microRNAs to intervene in diseases of aging.